Youth Empowerment Solutions for Positive Youth Development

DESCRIPTION (provided by applicant): The proposed study, Youth Empowerment Solutions for Positive Youth Development (YES), is a randomized controlled trial that compares youth in standard after school programs offering activity choice (e.g. sports, academic enrichment, arts) to youth assigned to an after school program that includes training in community development, formation of intergenerational partnerships and experience conducting community improvement projects. The study aims are to: 1) implement and evaluate an empirically developed intervention for empowering youth (YES) using a randomized controlled trial design in a high risk urban and suburban sample; 2) test a conceptual model that posits a causal relationship from youth empowerment processes to positive developmental outcomes; and 3) follow youth over time to assess sustainability of gains in healthy development. YES is a partnership between the University of Michigan School of Public Health, the Flint Community Schools and the Genesee County Intermediate School District. The study will include participants at eight high need middle schools with 21st Century after school programs. Developmental outcomes will be assessed at baseline, curriculum completion and at three and nine months post-intervention. Researchers have consistently found that participation in out of school programs enhances adolescents' well being and sense of worth, involves them in positive behaviors and helps them avoid involvement in problem behaviors. Although key elements of successful after school programs have been proposed (e.g., adult mentorship), the processes through which youth positive outcomes are achieved have rarely been empirically examined. Empowerment theory provides a unique conceptual framework for developing programs to enhance positive youth development because it incorporates the notion that health promotion requires not only that youth develop specific skills and positive assets, but also that youth become motivated to actively apply these skills and knowledge to become agents of positive change for themselves and in their communities. Thus, programs based on empowerment theory focus on building positive assets, connecting youth with local resources and adult role models, and engaging youth in community service activities. Ecological theory complements empowerment theory because it focuses attention on the social contexts in which youth develop interactions between these contexts, and the roles youth can play in these contexts (e.g., schools, communities). An intervention approach informed by these two theories should enhance positive youth development by engaging youth in relevant ecological settings where they can learn skills, practice those skills, and establish the social resources to effectively navigate the social contexts in which they find themselves and develop into healthy adults.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study aims to implement and evaluate an empirically developed after school intervention for empowering youth (YES) using a randomized controlled trail design in a high risk, urban sample; to test a conceptual model that posits a causal relationship from youth empowerment processes to positive developmental outcomes; and, to follow youth over time to assess sustainability of gains in healthy development Section 7. Project Narrative The proposed study aims to implement and evaluate an empirically developed after school intervention for empowering youth (YES) using a randomized controlled trail design in a high risk, urban sample; to test a conceptual model that posits a causal relationship from youth empowerment processes to positive developmental outcomes; and, to follow youth over time to assess sustainability of gains in healthy development __SpecificAimsTextDelimiter__ Section 2. Specific Aims Researchers have consistently found that participation in out-of-school programs enhances adolescents' well being and sense of worth, involves them in positive behaviors, and helps them avoid problem behaviors (Catalano et al., 1996; Coatsworth et al., 2006; Lerner et al., 2003; NRC/IOM, 2002; Wallace et al., 1995; Wallace & Williams, 1997; Zimmerman & Maton, 1992). Although theoretically important elements of successful after-school programs have been proposed (e.g., supportive adult relationships; opportunities for skill building; Eccles & Gootman, 2002), the processes through which such elements work to achieve positive youth outcomes have rarely been examined empirically. We propose to examine this question by implementing and testing the effectiveness of a positive youth development (PYD) intervention based on empowerment and ecological theories, in a sample of high-risk youth (11-14 years of age). Empowerment theory provides a useful conceptual framework for understanding how after-school programs enhance PYD by emphasizing specific skill and asset development and by providing supported opportunities to apply these skills and to become agents of positive change for themselves and in their communities (Zimmerman, 2000). Programs based on empowerment theory focus on building positive assets, connecting youth with local resources and adult role models, and engaging youth in community service activities. Ecological theory complements empowerment theory by focusing attention on the social contexts in which youth develop, interactions between these contexts, and roles youth play in various settings (e.g., schools, communities). We hypothesize that an intervention approach informed by these two theories will enhance PYD by engaging youth in relevant social-ecological contexts where they learn specific skills, practice those skills, and establish the social and cognitive resources that help them effectively navigate and change social settings. We also expect such an intervention will help youth develop the skills they need for PYD and to become healthy adults. This is the focus of the current proposal. Specifically, we will evaluate the effectiveness of an empowerment-based after-school intervention in a sample of low-income youth. Such youth, who are at high risk for internalizing and externalizing behaviors, may show particular benefit from participating in such programming (Arbreton et al., 2005; Cosden et al., 2001; Gerstenblith et al., 2005; Gottfredson et al., 2004; Riggs, 2006; Roffman et al., 2001; Vandell et al., 2005). The proposed longitudinal randomized controlled trial compares 7th graders assigned to an after-school program that includes training in leadership, community development and implementing community- improvement projects with 7th graders assigned to standard after-school programs. Youth Empowerment Solutions for Positive Youth Development (YES) includes a 16 week after-school curriculum that has undergone pilot testing, evaluation, and revision based on participant feedback during a 4 year developmental grant from the Centers for Disease Control (M. Zimmerman, PI). YES uses an empowering ecologically- focused, community-based strategy to promote positive youth development and reduce risk behavior. The YES program focuses on developing leadership skills, community pride, program planning, and resource mobilization. The YES program also trains local adult volunteers to assist and mentor youth while implementing the youth-planned community improvement projects. Eight public middle schools in Flint, MI and surrounding Genesee County were selected for the study because they host an existing after-school program for low income students that runs during the summer months (when YES projects are implemented). Youth will be recruited when entering Grade 7 and followed up through Grade 8. Outcome assessments include a pretest in Fall of Grade 7 and 3 posttests (G7 Spring; G8 Fall; G8 Spring). The conceptual model to be tested suggests that the YES program will enhance youth empowerment, which will result in more positive developmental outcomes and fewer problem behaviors compared to standard programming. Study aims are to: 1) implement and evaluate an empirically developed intervention for empowering 7th grade youth (YES) using a randomized controlled trial design in a high risk sample; 2) test a conceptual model that posits a causal relationship from youth empowerment processes to positive youth development outcomes; and 3) follow youth over time to assess sustainability of gains in healthy development.